Integrating EEG/MEG and fMRI

Our earlier basic studies have shown that MEG recordings during cognitive tasks have the ability to localize brain activity in comparable fashion to functional MRI. In specific, reduction in power in the beta frequency band at the cortex in general agrees with BOLD activation results. However, electrophysiological recordings such as the MEG/EEG have fine grained time dynamics not possible with other imaging techniques. We have also found that GABA (gamma-aminobutyric acid) concentration in the anterior cingulate cortex correlates with spatially localized resting MEG beta band power. We have expanded the cohort of well-matched subjects and isolated specific frequency band difference especially in the high gamma range (65 to 115 Hz). Differences in the degree of activation especially in frontal regions as indexed by beta desynchronization during a working memory task have been found between patients with schizophrenia compared to well siblings and healthy control volunteers. Previously we have seen that this activation reveals an interaction with genotype for the well-studied COMT marker. With groups of patients, siblings and controls matched for working memory task performance, patients show a distinct reduced DLPFC activation in apparent distinction to an increase in BOLD relative to task load. The MEG analysis isolates a working memory component that may reflect a different aspect of cortical processing. We have extended these results to examine differences in the high gamma band across groups. The relation of the different frequency bands to patterns of blood flow activation have revealed more specific targets for the neurophysiology underlying patient differences. We are now also comparing these differences in patients on and off anti-psychotic medication. It appears that medication may attenuate the PFC differences. We are also extending our genetic comparisons to examine modulation by SCN2A, a gene encoding the alpha-2 subunit of the sodium channel. Other studies have shown variation in cognitive performance across group, with MEG source localization showing significant differences in DLPFC and dACC for genotype by task interactions. Differences in network patterns and dynamics are key to understanding underlying pathology in clinical groups. Previously Bassett et al. have shown that functional network variations in patient groups can be related to behavioral outcomes on cognitive activities. We have found distinct patterns of the temporal sequence of brain regions involved in these memory tasks that show a variety of individual differences across subjects. We are continuing to utilize a variety of new measures to examine the flow of information in relation to cognitive task demand. We previously demonstrated that critical dynamics exist in resting MEG recordings and are now expanding this to compare patients with schizophrenia.